A Biobehavioral Approach to Explore the Migration-Food Insecurity Nexus as a Social Determinant of Cardiovascular Health

PROJECT SUMMARY/ABSTRACT
Food insecurity is a toxic stressor in the context of forced migration, which increases health risk and contributes to
health disparities. The proposed study will capitalize on the expertise, previous work, cultural backgrounds, and
community liaisons of leading scientists in migrant health, health disparities, and nutrition to conduct the first prospective,
longitudinal study to use a biobehavioral approach to characterize food insecurity as a social determinant of health in a
marginalized immigrant population about which little is known. In this study, our team will collect longitudinal, mixed
methods data from 450 Latino immigrants varying in migration context to characterize patterns of food insecurity over
time, and to examine how exposure to food insecurity and trauma – concurrently and prospectively influence risk for
CVD and diminished psychological well-being via the biological pathways of malnutrition and systemic inflammation.
Importantly, the proposed study will also identify individual and cultural factors that might ameliorate the detrimental
health effects of food insecurity and trauma on nutritional status and systemic inflammation among marginalized Latino
immigrants. In collaboration with established community partners, participants will be recruited from immigrant
camps/shelters on both sides of the U.S.-Mexico border, along with a control/comparison group of established Latino
immigrants living in the U.S. (≥ 5 years in U.S.). Using the inflammatory hypothesis of chronic stress as a conceptual
framework, the proposed study incorporates state-of-the-art biological markers and mixed methods to provide novel
information about biobehavioral mechanisms that underlie health risk and foster resilience across domains and levels.
Specific aim 1 is to characterize the food insecurity patterns of Latino immigrants varying in history of trauma and
migration context. Specific aim 2 is to characterize the concurrent and prospective relationships between food insecurity,
nutritional status, inflammation, CVD risk, and psychological well-being, and to identify disparities in these associations
among Latino immigrants varying in history of trauma and migration context. Specific aim 3 is to identify and understand
sociocultural and personal factors that moderate the associations between food insecurity, trauma, nutritional status, and
inflammation among Latino immigrants varying in history of trauma and migration context. Knowledge gained from the
proposed study will (1) fill a gap in the literature and propel scientific evidence about biobehavioral mechanisms through
which food insecurity influences cardiovascular health and psychological well-being among Latino immigrants, while
accounting for differences in the immigration experience that underlie health disparities; (2) inform culture and context
sensitive assessments, prevention efforts, and interventions to address food insecurity and its detrimental health effects;
and (3) guide advocacy and policy to address food insecurity among a marginalized immigrant population.

Public health relevance
PROJECT NARRATIVE The proposed study will collect longitudinal data from 450 Latino immigrant adults varying in context of migration to examine how exposure to food insecurity and trauma – concurrently and prospectively influence risk for cardiovascular disease (CVD) and diminished psychological well-being via the biological pathways of malnutrition and systemic inflammation, along with identifying individual and cultural protective factors. Using state-of-the-art biomarkers and mixed methods, this is the first study to identify multi-domain, multi-level factors that promote resilience in this immigrant population at the biological level, and therefore takes first steps towards the development of novel therapeutics to address disparities in CVD and psychological well-being among Latino immigrants. Knowledge gained from this study will propel scientific evidence about biobehavioral mechanisms through which food insecurity influences health risk and contributes to health disparities, as well as inform culture and context sensitive assessments, prevention efforts, interventions, and policies for a marginalized immigrant population about which little is known.